Team Dynamics, Networks, and Assembly (Team DNA)

DESCRIPTION (provided by applicant): Teams play an increasingly dominant role relative to solo scientists in medical practice, medical and public health research, and science more generally. The aim of this research is to understand the characteristics of successful teams, the leading indicators of impending team failure, and potential policies for increasing the productivit of team science and problem solving. To accomplish these aims we will develop a computational model of team dynamics, networks, and assembly parameterized by real world data on team collaboration. Our research will advance the understanding of team science by including the entire process that begins with the assembly of a team, continues through the dynamics of team communication and problem solving, and ends with either the production of team output or the premature dissolution of the team. Unlike previous models in which team networks are specified exogenously using stylized mathematical structures (such as preferential attachment or the Watts-Strogatz small world network model), teams in our model will endogenously self assemble from a pool of potential collaborators. Our model of team assembly will be parameterized by a unique dataset from the NSF supported web platform Nano HUB, which includes the interactions and scientific output of thousands of scientists working in the field of nanotechnology. Moreover, our model will incorporate not only the network structure of communication among team members, but also the quality of those communications. Because we have access to the full log of communications among Nano HUB team members, we will be able to apply measures of communication quality including Linguistic Style Matching (LSM) and Emotional Activation and Sentiment Analysis to parameterize the simulated communications in our computational model. In addition to parameterizing our model with input from real word data on team interactions, we will externally validate the computational model using two additional datasets on team collaboration, one from the Trans disciplinary Tobacco Use Research Center (TTURC) and a second from the web based software development host GitHub. The resulting validated computational model will serve not only as a test of theories of team dynamics, networks, and assembly, but also as a test bed for experimenting with potential policy interventions to encourage the development of successful teams and to prevent or mitigate the damage from team failures.

Public health relevance
PUBLIC HEALTH RELEVANCE: Teams play an increasingly dominant role relative to solo scientists in medical practice, medical and public health research, and science more generally. The aim of this research is to understand the characteristics of successful teams, the leading indicators of impending team failure, and potential policies for increasing the productivity of team science and problem solving. To accomplish these aims we will develop a computational model of team dynamics, networks, and assembly parameterized and validated using three real world datasets on team collaboration.